Data Mining and Functional Validation of SCORCH Datasets

Summary
The abuse of drugs is associated with treatment non-compliance, greater risk of viral transmission, and
more rapid clinical progression of HIV disease. The overarching hypothesis behind the present project is that
the exploration of gene regulatory networks in single cells will elucidate key pathogenic mechanisms that
underlie the effects of HIV and substance use disorder (SUD) and their detrimental interactions that will
indicate novel therapeutic targets for neuroinflammation, neurodegeneration, virus expression and persistence,
and cognitive impairment in the setting of HIV and SUD. To test the present hypothesis, we propose a data
mining campaign centered on a comparative analysis of cell type-specific gene regulatory networks or
interactomes reconstructed from the human and animal model single cell/single nucleus RNA-Seq (sc/snRNA-
Seq) and single nucleus assay for transposase-accessible chromatin-sequencing (snATAC-seq) from the
SCORCH program. To this end we will use a validated systems biology strategy for the reconstruction and
interrogation of a genome-scale gene regulatory network that proved exceptionally effective in deconvolving
molecular interactions in cancer, Alzheimer's disease, development, substance abuse (by our group), as well
as in the identification of therapeutic targets, mechanisms of action and synergistic activities of therapeutics.
The occasional but limited use of a drug is clinically distinct from dependent drug use, which is
characterized by the emergence of dependence and a negative emotional state when access to the drug is
prevented that drives negative reinforcement, a powerful source of motivation for drug seeking. Therefore, we
will validate the key genes identified both in vitro and in vivo in a state-of-the-art paradigm of voluntary
intravenous drug self-administration under long access (LgA) conditions, which leads to escalated (dependent)
drug intake that we implemented in HIV transgenic rats. Escalated drug intake in this paradigm is highly
relevant to human SUD as it has been suggested that it models all 7 of the criteria for drug addiction in the
Diagnostic and Statistical Manual of Mental Disorders (DSM)-IV and 7 of the 11 criteria in the DSM-V. HIV Tg
rats self-administering drugs in this paradigm display increased neural injury and neuroinflammation.
Overall, this collaborative interdisciplinary proposal integrating systems biology data mining centered on
the deconvolution of the gene regulatory networks at the single cell level, hierarchical validation strategies
including state-of-the-art behavioral paradigms of volitional drug intake, single cell level transcriptomics, and
state-of-the-art behavior methods in HIV Tg and wild-type rats, will elucidate key mechanisms that underlie the
detrimental interactions of HIV and SUD on disease progression, virus expression and persistence. The results
will indicate transformative new mechanistic hypotheses that may lead to novel therapeutic concepts for SUD
in the setting of HIV and will establish key resources for the neuroHIV field to be made publicly available
through the SCORCH data coordination center and other public repositories.

Public health relevance
Public Health Relevance Substance use disorder (SUD) in people with HIV (PWH) is associated with treatment non-compliance, greater risk of viral transmission, and more rapid disease progression. To investigate the molecular mechanisms behind the interactions of HIV and SUD, this interdisciplinary project will carry out a data mining campaign centered on a comparative analysis of the gene networks associated with SUD, HIV, and their interaction from the single cell/single nucleus RNA-Seq datasets generated by the SCORCH components to identify the molecular drivers of disease progression or resilience and therapeutic targets to improve neuropsychological functioning in PWH with SUD comorbidity. To this end we will bring to bear computational methods to elucidate the key genes driving the altered gene expression at the single cell level, which will provide a framework for new testable hypotheses on the mechanisms underlying the neuropathogenesis of the neuronal damage and neuroinflammation in the context of SUD in PWH that can reveal new pathogenic concepts and more effective therapeutic targets to improve neuropsychological functioning in PWH and SUD comorbidity.